Cell-Cell Interactions In Alzheimer's disease and related dementias

Alzheimer’s disease (hereafter, AD), a progressive neurodegenerative disorder, is fatal with no effective
cure to date. AD manifests as gradual decline in cognitive functions of learning and memory due to
selective atrophy of the hippocampus and frontal cerebral cortex in the brain. The neurodegeneration
associated with AD also coincides with accumulation of amyloid-beta 42 (Aß42) plaques. The accumulation
of Aβ42 plaques and NFTs in AD triggers progressive neurodegeneration across brain regions. It is not
clear how cellular changes contribute to the progression from an initial asymptomatic period into a phase
of stark cognitive decline. The molecular genetic mechanisms underlying the Aβ42 mediated
neurodegeneration are not fully understood. Many strategies including model organisms have been
devised. Drosophila melanogaster, fruit fly, with a large array of genetic tools, and similar genetic makeup
to humans is an excellent model for human diseases including AD. Drosophila can be used for high
throughput genome wide- and for therapeutic compound screens. We have established a transgenic fly
model where we misexpress high levels of human Aß42 polypeptides in the retinal neurons of the eye,
which exhibits AD like neuropathology of progressive neuronal death. This stable transgenic line exhibits
Aß42 mediated cell death in nearly 100% flies at 29oC. Our goal is to employ our Drosophila eye model to
identify (a) downstream target genes and (b) reporters/ sensors to detect AD, and (c) look for complex
interaction between Aß42-producing and wild-type neurons during Alzheimer’s neuropathology. We
identified the highly conserved growth regulatory Wingless (Wg)/Wnt signaling pathway as the dominant
modifier of Aß42-mediated neurodegeneration. The first aim is to determine the involvement of Wg
signaling in Aβ42-mediated neurodegeneration. Wg signaling has been studied in cell survival and
differentiation, and not in neurodegeneration. We will test if modulation of the Wg signaling pathway can
modulate Aβ42-mediated neurodegeneration. We will test if the reporters/sensors of the Wg pathway can
be used to detect Aß42-mediated neurodegeneration. In the second aim, we will determine if Wg pathway
activation triggers neurodegeneration in wild-type cells or in Aβ42-expressing cells. We will use our two
clone systems to determine if there is any cross-talk between the wild-type neurons and Aß42 producing
neurons. Our hypothesis is that aberrant Wg signaling might trigger cell death in wild-type neurons. These
proposed studies aim to provide a useful blueprint to study cross-talk between cell populations in
neurodegenerative disease. This may potentially identify new biomarkers that can be differentially
regulated between Aβ42-expressing and WT neurons. Better understanding of the local context of cell
death in progressive neurodegenerative disease is a vital next step in developing new interventions to slow
or halt disease progression.

Public health relevance
Alzheimer's disease (AD), a progressive neurodegenerative disorder, is characterized by cognitive dysfunction of learning and memory, which results in selective atrophy of the hippocampus and the frontal cerebral cortex. Using fruit flies to model Alzheimer’s disease (AD), we will study the role of the highly conserved Wingless/Wnt signaling pathway in neurodegeneration using mosaic models to study cross-talk between cell populations that triggers the cascade of events leading to overall disease progression. This study will contribute to (i) a better understanding of the molecular genetic underpinnings of AD in models and AD patients, and (ii) identification of new biomarkers for early AD detection, and possibilities of identifying new drug and therapeutic targets for AD.